Disparities in breast cancer treatment using Granulocyte colony-stimulating factors and CDK4/6 inhibitors between African and European ancestry individuals in two large Electronic Health Records

PROJECT SUMMARY: OVERALL
Cancer health disparities based on factors such as race and ethnicity are the result of a combination of
socioeconomic, environmental, behavioral, and biological factors. These disparities impact cancer incidence,
prevalence, mortality, survivorship, financial burden, and screening rates. The long-standing and mature Meharry
Medical College (MMC), Vanderbilt-Ingram Cancer Center (VICC), Tennessee State University (TSU) Cancer
Partnership (MVTCP), continues to provide and expand upon an exceptional cancer research and training
environment to support the efforts of diverse investigators in addressing disparities. These efforts span across
multiple disciplines to study the determinants of cancer health disparities at an NCI-designated comprehensive
cancer center (VICC) along with enhancing research infrastructure, capacity-building, and impact at two minority-
serving institutions (MMC and TSU). Collectively, over the past twenty years of partnership, these collaborative
efforts provide a robust infrastructure to address and overcome cancer disparities while expanding research
opportunities, recruitment and training. Our Triad has benefited from sustained and strong collaborative
interactions between the three partner institutions, resulting in robust community and educational outcomes.
Moreover, the geographical placement of this Triad in Tennessee, a region with some of the highest cancer
incidence and mortality rates in the United States, also provides a unique opportunity for our Partnership to
positively impact outcomes for cancer patients in this geographical region. This region continues to have
significant cancer health disparities in lung, breast, prostate, and colorectal cancers. In order to meet our ultimate
goals of overcoming cancer disparities while simultaneously strengthening research impact, the overall
objectives of this competing renewal application are to: 1) increase the participation in traditional, investigator-
initiated cancer research projects awarded to MMC and TSU faculty with collaborative guidance by senior VICC
faculty; 2) increase the number of investigator-initiated awards to VICC junior faculty that address cancer
disparities; 3) recruit, train and retain early-stage investigators to become independent leaders in cancer health
disparities and cancer research and training; 4) expand MVTCP participation in national oncology treatment and
interventional trials; 5) strengthen the physical and intellectual infrastructure for research at MMC and TSU; 6)
facilitate partnerships between community organizations and academic researchers, leading to hypothesis-
driven research projects that include the involvement of a community health educator; 7) increase the number
of MMC and TSU trainees engaged in cancer research; and 8) increase awareness of cancer research
opportunities and careers for minority high school, undergraduate, graduate and medical students through the
Pathway to Discovery program.

Public health relevance
PROJECT NARRATIVE: OVERALL The well-established Meharry Medical College/Vanderbilt-Ingram Cancer Center/Tennessee State University Cancer Partnership (MVTCP) triad provides an exceptional environment to identify and address health care inequities in cancer seen in underrepresented minorities. The proposed research projects, cores, and shared resource cores will grow research and propose evidence-based solutions address to these inequities. Further, the development of expanded research infrastructure at MMC and TSU, enhancement of minority education programs, and improvement to the effectiveness of cancer-related activities will address health care disparities in the greater Nashville geographical region, with the ultimate goal of contributing to reducing health disparities among cancer patients in minority and underserved communities.